In vivo selection of gene modified hepatocytes

Today the clinical application of many otherwise promising new strategies for liver directed gene and cell
therapy is hampered by their inherent quantitative inefficiency. Here we propose to use in vivo selection to
overcome these problems. We will develop clinically applicable ways to use small molecule drugs to select
genetically modified hepatocytes in vivo and thereby cross the quantitative threshold required for permanent
therapeutic benefit. We have identified the fever medication acetaminophen (APAP) as excellent candidate for
this approach.
Three specific aims are designed to fully validate these novel method for in vivo selection of therapeutically
modified hepatocytes.
In Aim 1, we will develop integrating rAAV vectors (Generide vectors) that can be selected by APAP and in aim
2,conditionally selectable lentiviral vectors will be generated. Both will be validated in metabolic disease
models. In Aim 3, we will apply the results of Aims 1&2 to human hepatocytes. Selection of genetically
modified human hepatocytes will be carried out in liver chimeric mice.

Public health relevance
Several promising new methods for liver directed gene therapy are too inefficient to be practical in humans. We have developed methodology to selectively expand hepatocytes that have been modified by a therapeutic transgene. In this method gene corrected hepatocytes can be selected by giving the commonly used fever medicine acetaminophen to animals treated with gene therapy. This new method has the potential to significantly improve the efficiency gene repair and lentiviral gene therapy as well as cell transplantation in the liver.